HGRP Logistical Coordinating Center

PROJECT SUMMARY (Project 3: HGRP Logistical Coordinating Center)
Efficient and effective logistical and scientific coordination is critical to the continued success of the HPRC, and
to maximizing the value of the data, resources and tools produced by the consortium. We propose to continue
the successful management infrastructure of the HPRC Logistical Coordinating Center (LCC) to manage the
Human Pangenome Reference Consortium. We will continue to facilitate the construction, maintenance and
dissemination of the pangenome reference and associated tools by providing the organizational foundation for
the consortium. To do so we will maintain both internal and external facing HPRC websites, support all
consortium communications, budgetary planning and reporting, track publications and presentations, organize
annual meetings and cross-consortia meetings with adopter programs, support both domestic and international
outreach and educational activities, provide the global scientific community access to protocols, tools, data, and
other HPRC resources, and solicit and respond promptly to community feedback. We will support the
development of the international Human Pangenome Project, which will continue beyond the tenure of the
HPRC.